Characterizing representational geometry and learning across primate visual streams

Project Summary
The primate visual system must balance competing demands, including representing objects and places in a
format that is both abstract enough to be recognizable under novel conditions, but also specifically bound to
other objects and places via contextual associations. How the visual system achieves this balance remains to
be understood, as current artificial neural network (ANN) models fail to exhibit this same robustness and
flexibility. One notable difference between ANNs and the brain is that the former preponderantly model the visual
system as a single feedforward hierarchy, while ample evidence suggests that the latter in reality includes
numerous parallel hierarchies with possibly complementary propensities for abstraction versus granularity. Aim
1 addresses such variations in representational geometry over cortical space by contrasting joint encoding of
multiple objects in inferotemporal cortex (IT) and parahippocampal cortex (PHC) of common marmoset monkeys.
I hypothesize that representations of different objects in IT will be comparatively independent of each other, while
PHC will more nonlinearly encode groups of objects. Artificial neural networks trained on various loss functions,
architectures, and training diets will then be used to attempt to model these phenomena. Aim 2 will investigate
variation in representational geometry over the course of familiarization with a novel virtual environment over
several days. I hypothesize that neural representations of different views of the learned environment will acquire
the same correlation structure as the images themselves in the underlying latent factor space. This research will
suggest new, non-standard neural network architectures for modeling vision, help us make more precise
predictions about the effects of stroke or lesion on different parts of the brain, and better understand the
underpinnings of disorders like attention deficit hyperactivity disorder, autism, frontotemporal dementia, and face
and object agnosias.
The training plan described in this proposal will afford me proficiency in new experimental and theoretical
methodologies, including large-scale, multi-area electrophysiological recording, the use of common marmosets
as a model organism for visual neuroscience, deep neural network modeling, and advanced data analysis
techniques for understanding the structure of neural representations. I will receive expert training in
electrophysiology and machine learning from my sponsor Dr. Elias Issa, as well as in theoretical neuroscience
and advanced neural data analysis methods from my co-sponsor Dr. Stefano Fusi. This work will be conducted
at Columbia University’s Zuckerman Institute, a world-class neuroscience research and training institution whose
faculty specialize in approaches ranging from molecular to systems to theoretical.

Public health relevance
Project Narrative The ventral stream of the visual system has long been known to contribute to aphasia or memory loss when damaged, however it remains unclear how specific parts of the ventral stream contribute to these deficits. The current study will separately characterize responses in the ventral stream, and computationally model different sub-parts of the ventral stream, including the perirhinal (Pr) and parhippocamapal (Ph) subdivisions. Understanding the ventral visual stream at this level of granularity will allow more precise predictions of how damage to different parts of the brain might affect behavior, and therefore open avenues for the development of novel diagnostic tools for localizing the locus of a lesion neurologically.